Modernizing the family-based association testing (FBAT) approach and its software implementation in the FBAT-program

Developed for linkage and candidate gene studies, family-based association tests (FBATs) have played a
fundamental role in the disease mapping efforts of the human genome project. Originally conceived for studies
of affected offspring and their parents, FBATs are joint tests for linkage and association that are robust against
confounding due to population substructure by virtue of their design. In terms of the trait/phenotype of interest,
FBATs do not require distributional assumptions. In combination with its user-friendly software implementation,
the robustness and model-free features of FBAT made the software a frequently used analysis tool that has
contributed to several thousand research projects world-wide. Since its first release in 2001, the package has
been constantly adapted to the changing analysis needs of its user community. The approach has been extended
to general pedigrees, complex phenotypes, and haplotype analyses. With the arrival of genome-wide association
studies (GWAS) and whole-genome sequencing studies (WGS), multiple-testing strategies and rare-variant
analysis approaches have been developed and implemented, which has enabled its continuing use in current
WGS studies. However, the full potential of FBAT for WGS studies is restricted by the available null-hypotheses
that can be tested and by its current software implementation that does not support modern, efficient file-formats
for genotype data and that does not utilize parallel/distributed computing. In this application, we will expand the
testing capabilities of FBAT by implementing additional null-hypotheses that are relevant for the analysis of WGS
data. In WGS analyses, multiple association signals are often detected within the same genomic region and it is
unclear whether they stem from multiple disease susceptibility loci (DSLs) or whether a single DSL creates
multiple association signals through linkage disequilibrium. We will address this research question by enabling
FBAT to condition the test statistics on other loci with association signals in the same region and thereby, assess
the independent contribution of the tested loci to the association. Many genetic association signals have been
discovered in studies of unrelated individuals with large sample sizes and relatively small effect sizes. These
findings may be false positives or caused by unmeasured confounding in the association analysis. While the
contribution of family-based studies is often limited in large scale mapping efforts as their sample sizes are much
smaller than the number of unrelated samples, family-based studies can play a pivotal role in validating findings
given their robustness against genetic confounding and their non-parametric modelling of the outcome. We will
introduce equivalence testing into FBAT, which will allow the user to conclude the absence of a genetic effect of
meaningful magnitude. Regarding the software implementation, FBAT will be able to accommodate commonly
used binary file formats for the genetic data in addition to the plain text files, which are currently the only
supported files formats. To take full advantage of modern Linux clusters with multi-core CPUs, we will add parallel
and distributed computing capabilities to FBAT.

Public health relevance
Narrative Over the last twenty years from the early days of linkage and candidate gene studies to the ongoing whole- genome sequencing efforts, the family-based association testing (FBAT) approach and its software implementation have become a popular and essential tool for the genetic association analysis of family data. The model-free character of the approach, its robustness against any form of genetic confounding, and the user- friendly implementation have fostered the research of a large user community and contributed to several thousand research papers. In this application, to better address the current and future data analysis challenges of the community, we propose to modernize the FBAT program by incorporating new methodological features and improving the technical capabilities of the implementation.